Understanding Vangl2-mediated mesenchymal thinning during lung sacculation

Project Summary
The majority of preterm births occur while the lungs are in their final embryonic developmental stage,
sacculation. However, our understanding of how the delicate architecture of the distal lung develops during this
stage is extremely sparse, limiting our capacity to develop therapeutic interventions for neonatal infants
affected by respiratory diseases. The planar cell polarity (PCP) pathway has recently been shown to play a
pivotal role in sacculation, a developmental process during which the epithelial surface area of distal airways
expands while the mesenchyme between adjacent airways thins. In vertebrates, the PCP pathway regulates
convergent-extension during key developmental processes such as gastrulation and neural tube closure. My
preliminary data reveal that, although epithelial PCP is not required for lung morphogenesis, the core PCP
gene Vangl2 is specifically required in the pulmonary mesenchyme to achieve normal sacculation. I
hypothesize that Vangl2 regulates cytoskeletal machinery to drive mesenchymal thinning in a way that parallels
how convergent-extension intercalations elongate the body axis. Confirming this hypothesis would support a
model in which cell rearrangements in the pulmonary mesenchyme actively shape the distal lung during
sacculation and would delineate a novel mesenchymal PCP pathway. To test this hypothesis, I will determine
the cellular mechanisms by which Vangl2 promotes mesenchymal thinning during sacculation through a live-
imaging approach using transgenic mice (Aim 1). I will then use a joint genetic and biochemical approach to
map the molecular players through which Vangl2 drives this mesenchyme-specific process (Aim 2).
Successfully completing these aims will deepen our understanding of how Vangl2 functions at both the cellular
and molecular level to facilitate dramatic changes in mesenchyme morphology during lung development.
Moreover, they will elucidate, for the first time, a specific mechanism for mesenchymal thinning during
sacculation. This knowledge will not only inform future research into therapies that may enhance or
supplement Vangl2 function to treat preterm infants born with severely underdeveloped lungs, but will also
illuminate a developmental pathway that may prove useful in engineering lung tissues to treat additional
respiratory conditions.

Public health relevance
Project Narrative Understanding the mechanisms that underlie lung development will not only inform how we treat neonatal lung disease, but will be crucial in understanding how to eventually bioengineer lung tissue. Recent evidence suggests that the planar cell polarity (PCP) pathway plays a role in lung sacculation, an understudied yet critical stage of embryonic lung development. The proposed study will investigate how Vangl2, a core PCP protein, regulates sacculation at both the cellular and molecular levels, and may offer new insight in how to facilitate normal development in preterm infants born with underdeveloped lungs.